A lab-on-a-chip device for measuring multiple biochemical and biophysical biomarkers of Alzheimer’s disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most common form of dementia, causing 50–75% of all dementia cases, and
currently affecting approximately 50 million people worldwide. A major problem in AD research is that we still
do not have accepted measures of biomarkers that are useful in clinical trials for AD, which makes it difficult to
enroll the most relevant cohorts and test the mechanism of action of drug candidates. This is compounded by
the fact that current biomarker testing is dominated by cerebrospinal fluid (CSF) analysis and positron emission
tomography (PET) scans. CSF testing is invasive, while PET scans are expensive and not easily accessible.
Research on alternative drug targets for AD has recently started to grow, and as a result, there is a strong
need for new biomarker targets and new modalities to measure these biomarkers. These modalities would be
ideally low-cost, non-invasive, and easily scalable. Raman spectroscopy has shown good promise in
distinguishing early-stage AD from cognitively healthy controls, while mass spectrometry has shown good
potential in distinguishing certain neurological disorders from cognitively healthy controls using the novel
concept of conformational biomarkers. Different from classical concentration-based disease biomarkers,
conformational biomarkers reflect the changes in structure. However, conventional Raman spectroscopy
systems are not scalable, and mass spectrometry is both expensive and time consuming. An emerging
concept is waveguide enhanced Raman spectroscopy (WERS). Along with providing increased light
efficiencies, it can also make use of current CMOS fabrication techniques, allowing nanophotonic chips to be
mass produced. In terms of conformational sensing, light scattering spectroscopy has been demonstrated as a
reliable technique for sensing nanoscale changes in conformational properties.
Given these findings, we hypothesize that a scalable photonics-based lab-on-a-chip device can be used for the
simultaneous investigation of multiple novel biochemical and biophysical AD biomarkers. These hypotheses
will be addressed in the experiments of the following Specific Aims: (1) Develop a low-cost, scalable, and label-
free testing platform based on waveguide enhanced Raman spectroscopy to detect existing and novel
biomarkers in blood plasma; and (2) Develop a prototype label-free testing platform based on light scattering
spectroscopy for characterizing misfolded proteins in CSF samples. Should these aims be successful, it opens
the possibility of developing a scalable lab-on-a-chip device for straightforward screening of AD patients and
monitoring of disease progression, both of which are critical requirements for future AD therapeutic
development. The results would also have broad implications for other neurological disorders.

Public health relevance
PROJECT NARRATIVE These exploratory studies could lead to the development of a mass producible device that uses a simple blood sample to identify people most suited for clinical trials of Alzheimer’s disease therapeutics. The same device could also be used for monitoring disease progression throughout the trial.